A modeling framework and arena for measuring contextual influences of behavior

PROJECT SUMMARY
Social behaviors are essential for survival and reproduction. They also evolve quite rapidly and can
vary even among closely related species. Traditionally, social behaviors are very difficult to study
because of the complexity of their input, requiring conspecifics to trigger aggressive, cooperative,
parental, or reproductive behaviors. Additionally, contextual data is important, such as hierarchical
status and environmental factors can also play a role. T his grant will propose to create a
behavioral arena capable of mimicking natural environments that are required for social reproductive
behaviors, including interactions between a large number of conspecifics, environmental factors
such as male displays, and contextual data such as hierarchical status between various males. Tools
will be created to track animals in this arena and build a computational frame work to measure
and compare social behavioral dynamics. This work will utilize Lake Malawi cichlids, a powerful
evolutionary model for identification of genes and neural circuit changes associated with differences
in behavior. This project will generate new tools and datasets for modeling social behaviors, paving the
way for a large-scale R01.

Public health relevance
PROJECT NARRATIVE Social behaviors are critical for survival and their defects are hallmarks of many neurological diseases. To enable us to identify genetic changes that affect behavior, we will design naturalistic behavioral arenas, automated tracking assays, and new behavioral frameworks for the study of Lake Malawi reproductive behaviors in contexts that include male competition and female choice. Use of this new behavioral assay will allow us to understand how behavior evolves and identify underlying neural circuits that are conserved even in humans.